The effect of severe obesity on regional lung perfusion in acute hypoxemic respiratory failure

Severe obesity, a population of over 30 million adult Americans, increases rates of acute
hypoxemic respiratory failure (AHRF) and leads to cardiopulmonary complications and
premature death. Unfortunately, AHRF in severe obesity remains insufficiently characterized,
and there are no targeted pharmacologic therapies for this population. The K23 award
application aims to address critical knowledge gaps for the care of acutely hypoxemic patients
with severe obesity and develop methodologic expertise in functional lung imaging and
endothelial biology for the candidate. The mentored research has two aims. Aim 1 will define the
association between severe obesity and regional lung perfusion in a novel multicenter AHRF
cohort containing functional imaging and clinical data. Aim 2 will test the effect of severe obesity
on the pulmonary vasoreactivity to inhaled nitric oxide in a prospective cohort of mechanically
ventilated patients with AHRF. Contributions from diabetes and sex will be assessed for both
aims. The proposal's central hypothesis is that severe obesity impairs regional lung perfusion
and vasoreactivity in AHRF. The candidate's long-term goal is to be an independent patient-
oriented translational researcher who develops and tests precision diagnostics and therapies for
AHRF patients with severe obesity. The research aims directly inform the training goals to 1)
develop advanced knowledge of functional lung imaging techniques, 2) gain methodologic
expertise in endothelial biology, 3) acquire skills in clinical trials in critical care settings, and 4)
obtain certification in obesity medicine. The training plan includes hands-on laboratory
experience, selected graduate coursework, planned research manuscripts, weekly seminars, and
frequent mentor meetings that build on a solid clinical epidemiology and biostatistics
background. The research project, institutional environment, mentorship team, and content
advisors are ideally suited to the candidate's career development. This formative work has the
potential to result in a significant shift in the focus of care of AHRF patients with severe obesity
by targeting vascular derangements as a guide to personalized therapy. The K23 award will
support the candidate's transition to lead independent research aimed at 1) integrating
perfusion imaging into the care of AHRF patients with severe obesity, 2) investigating the role of
nitric oxide signaling dysfunction on AHRF progression in severe obesity, and 3) identifying
pathways of perfusion dysregulation as possible targets for novel therapeutic approaches.

Public health relevance
Severe obesity is a significant risk factor for acute hypoxemic respiratory failure, cardiopulmonary complications, and premature death. The proposed research will characterize the effect of severe obesity on regional lung perfusion and vasoreactivity during acute hypoxemic respiratory failure. The K23 career development award will support the training to establish the candidate as an independent patient-oriented translational researcher in critical care medicine.